RNA methylation in the progress of heart failure

PROJECT SUMMARY:
Cardiovascular diseases are leading cause of morbidity and mortality in the US. Cardiac fibrosis is a
fundamental mediator of heart failure progression. Following myocardial stress, fibroblasts are activated,
resulting in extracellular matrix deposition in the heart's different regions and leading to cardiac fibrosis and
subsequent cardiac dysfunction. Thus, understanding the molecular mechanisms underlying cardiac fibrosis
is crucial for developing effective therapies. Several signaling cascades have been identified as key regulators
of fibrosis. Among these, b-catenin-mediated activation of profibrotic genes expression is crucial in the
progress of cardiac fibrosis. However, the precise mechanism that regulates b-catenin nuclear translocation
(a key step for b-catenin-mediated fibrosis) during cardiac injury remains incompletely understood. The
premise of this proposal is based on the strong preliminary data that confirm the contribution of RAPGEF5 (a
guanine nucleotide exchange factor) mRNA methylation in the regulation of β-catenin nuclear translocation
and its impact on the progress of cardiac fibrosis. RNA modifications, specifically methylation, are known to
be important in regulating mRNA stability, splicing, and translation, but their role in cardiac fibrosis is not well
studied. The central hypothesis of this application is that activation of METTL3 by TAC (pressure overload)
leads to increased stability of RAPGEF5 mRNA, which promotes β-catenin translocation into the nucleus,
resulting in the activation of fibrotic genes and progress of cardiac fibrosis. We hypothesize that inhibiting or
deleting METTL3 will mitigate adverse cardiac remodeling by reducing fibrosis.
In Aim 1, we will investigate the direct link between METTL3 activation and cardiac fibrosis progression using
a fibroblast-specific METTL3 transgenic mouse model subjected to pressure overload-induced heart failure.
In Aim 2, we will elucidate the mechanisms by which METTL3 regulates RAPGEF5 mRNA stability and β-
catenin-mediated fibrotic signaling. This will involve overexpressing METTL3 in fibroblasts both in vivo and in
vitro, followed by examination of RAPGEF5 and β-catenin expression, stability, and fibrotic signaling.
Finally, in Aim 3, we will explore the therapeutic potential of inhibiting METTL3 in a mouse model of pressure
overload-induced heart failure. We will treat mice with a pharmacological inhibitor of METTL3 (STM2457),
either before the onset of heart failure (prevention strategy) or two weeks after (treatment strategy), and then
assess various biochemical parameters as described in Aims 1 and 2.

Public health relevance
Relevance in Public Health (Narrative): Despite current treatments, the incidence of heart failure along with its associated morbidity and mortality continues to rise and represents a substantial health and economic burden on the US. As development of specific therapeutics is urgently needed, we propose to investigate the role of epitranscriptomic modification in RAPGEF5 and ctnnb1 mRNAs via METTL3 and its impact on cardiac fibrosis in hypertrophic heart failure model. Our findings will lead to deeper understanding in the mechanisms of cardiac fibrosis on one hand and innovative therapeutic interventions on the other.